Metastable Crystallins: Structure and Stabilization

Abstract
α-Crystallin is a complex macromolecule that accounts for nearly 40% of the adult lens proteins. The
chaperone-like activity of α-crystallin, which was discovered nearly three decades ago, is implicated as a key
component in the maintenance of lens transparency by suppression of crystallin aggregation. It was found that
the deletion of 21-28 and 54-61 regions of αB-crystallin leads to increased chaperone-like activity (activation,
gain of function). Understanding the molecular organization and properties of crystallin subunits in activated
chaperones would help answer questions on how α-crystallin chaperone-like activity might be harnessed and
manipulated for the development of protein-based therapeutics. It is hypothesized that the increased αB-
crystallin chaperone-like activity in deletion mutants stems from new type of oligomers where subunit–subunit
interactions lead to the exposure of “cryptic” chaperone sites in the native oligomers. Studies show a
recombinant αB-crystallin expressed after deleting either 54-61 or 21-28 and 54-61 sequences (resulting in a
protein designated as αBΔ54-61 and αBΔ21-28,Δ54-61) was found to form smaller oligomers than the wild-
type protein but to show up to ~25-fold increase in chaperone-like activity. The experiments proposed in this
proposal will uncover the molecular changes that drive the increased chaperone-like activity in αBΔ21-28,Δ54-
61 and αBΔ54-61. The aims of the application are 1) Uncover the molecular changes in the activated αB-
crystallins, (αBΔ54-61 and αBΔ21-28,Δ54-61), 2) determine the biological implications of enhanced
chaperone-like activity of engineered proteins in the cell culture and whole lens culture system. Novel
crosslinker(s) will be used to gain fresh insights into the “cryptic” chaperone sites getting exposed in the
activated crystallin. The studies will also make use of site-directed mutagenesis and mass spectrometric
analysis to uncover the molecular changes at subunit interaction level in activated oligomers. To see whether
the activated αB-crystallin can be exploited to protect cells from oxidative injury, the effects of stress-inducing
agents such as H2O2 and sodium iodate will be investigated in HEK293 and ARPE-19 cells in presence of
activated crystallins. Further, the ability of activated chaperones to suppress aggregation and toxicity of fibril-
forming β-amyloid will be investigated both in vitro and ex-vivo. The long-term goals of the studies are to
understand the structure–function relationship of activated αB-crystallins and develop crystallin proteins that
have therapeutic value in protein conformational diseases and oxidative stress conditions.

Public health relevance
Project narrative Understanding how eye lens crystallins can be activated and whether the activated crystallins have better cellular protection capacity will help future studies of identifying most active form of crystallins to treat disease conditions. The proposed study will include studies on the changes occurring in crystallin protein molecule during activation and testing the active preparations in cell culture models replicating stress conditions.